Extensive drug histories result in compulsive appetite: functional identification of punishment-reactive neural network re-organization in the rostromedial tegmental nucleus

PROJECT SUMMARY
Binge-eating disorder (BED) and bulimia nervosa (BN) are potentially life-threatening eating disorders that
share behavioral and brain similarities, genetic risk factors and higher-than-expected comorbidities with drug
addiction – suggesting a common etiology. However, no mechanistic study has examined this possibility due in
part to the lack of an animal model linking eating disorders and drug addiction. Like drug craving and use in
drug addiction, food craving and eating in BED/BN persist despite adverse consequences (punishment). Our
finding from rats indicates that extensive cocaine and alcohol histories, known to trigger addiction-like brain
changes and punishment-resistant “compulsive” drug intake in rats, trigger punishment-resistant food intake or
“compulsive appetite”. These results provide an animal model for studying the neurobiological mechanisms
manifesting as compulsive behavior across eating disorders and drug addiction. Food motivation is thought to
be regulated by both homeostatic (caloric) and non-homeostatic (hedonic/incentive) systems. The homeostatic
system detects energy shortages and elicits food intake. However, like compulsive drug motivation, our finding
suggests that compulsive appetite is driven by non-homeostatic ‘motivational/habitual’ dysregulation. Like
cocaine and alcohol histories, obesogenic diet histories also led to compulsive appetite via non-homeostatic
dysregulation. Thus, similarly common – rather than history-specific – changes in brain sites that control non-
homeostatic regulation, such as reward circuits, likely cause compulsive appetite. Our collaborator Dr. Jhou’s
group has found that punishments suppress appetitive behavior by recruiting neurons in the rostromedial
tegmental nucleus (RMTg), which in turn inhibits reward circuits. Available evidence indicates that extensive
drug histories [1] degrade excitatory afferents to RMTg, [2] decrease punishment-reactivity of RMTg neurons
and [3] impair inhibitory control of RMTg efferents on reward circuits. Such brain changes would entail “less
brakes” on non-homeostatic regulation, potentially manifesting as compulsive appetite. Accordingly, like
extensive cocaine/alcohol/obesogenic diet histories, [4] RMTg inactivation results in punishment-resistant
compulsive appetite. Based on the rigor of previous research and premise above, this project will test the
central hypothesis that extensive cocaine/alcohol/obesogenic diet histories result in punishment-resistant
compulsive appetite via decreased neural punishment-reactivity in the RMTg circuitry. RMTg contains neurons
selectively reactive to punishments or rewards – likely exerting distinct behavioral functions. Each Aim is thus
designed to selectively profile and interrogate punishment-reactive RMTg neurons/afferents/efferents (as Aims
1/2/3) using neural activity-specific methods based on the activation marker Fos. The results will reveal neural
activity network reorganizations that are functionally linked to compulsive appetite – an overlapping ramification
of extensive drug and obesogenic diet histories. Our hope is that such knowledge will help identify common
therapeutic targets for compulsive behavior across drug addiction and eating disorders.

Public health relevance
PROJECT NARRATIVE The purpose of this project is to elucidate the brain circuitry responsible for addiction-like food motivation or “compulsive appetite” – an overlapping ramification of extensive drug and obesogenic diet histories – in rats. Candidate brain circuitry will be identified and validated in functional units of brain cells thought to provide the “brake” on food motivation. Our hope is that such knowledge will help developing medications for compulsive behavior, perhaps, across eating disorders and drug addiction.